Effects of Noise Exposure Across the Lifespan on Balance and Stability in Older Adults

Abstract
Loss of stability and falls is a major risk factor for injury and death in older adults. Previously overlooked,
lifetime noise exposure has been shown to cause damage to the vestibular periphery; although, animal models
and human studies that can provide a mechanistic basis connecting noise-induced vestibular dysfunction and
age-related fall risk are limited. The vestibular system plays a critical role in detection of head movements and
orientation with respect to gravity and is essential for normal vision and postural control. Due to their
anatomical proximity to the cochlea, the otolith organs are exposed to sound pressure and are at risk for noise
overstimulation, which may contribute to vestibular dysfunction. Recent studies have linked noise
overstimulation to decreased vestibular nerve activity and loss of a specialized class of irregularly firing
vestibular afferents which exhibit enhanced sensitivity to acceleration. It is likely that these afferents play an
important role initiating postural compensation for abrupt changes in head or body position due to their
physiological characteristics and their projection to secondary vestibular neurons that project to the spinal cord.
Therefore, the effects of noise may accelerate disability associated with natural aging. The goal of this
supplement is to purchase equipment to measure vestibular evoked myogenic potentials (VEMP) in human
participants, and thus assess changes in otolith function associated with noise exposure. The inclusion of
VEMP reflects Reviewer recommendation to use vestibular-evoked myogenic potentials to directly assess how
noise exposure might affect otolith function in humans and compare to outcomes in the rat. The VEMP
experiments will be performed in lieu of the dynamic tilt detection experiments proposed in the parent grant.
VEMP testing can be done in the same, or shorter amount of time to assess otolith function under dynamic
stimulation conditions. This supplement will allow us to incorporate a well-characterized physiological
assessment in human subjects to evaluate the underlying mechanisms in increased falls and fall risk due to a
history of noise exposure in older adults. The susceptibility of these individuals to potentially fatal falls
underscores the need for a systematic approach, that can eventually result in improved training and
rehabilitation methods to be used with this population.

Public health relevance
Project Narrative Falls in older adults are common, have high societal and monetary costs, often lead to injury and can even be fatal. This project will investigate how natural aging is accelerated by lifetime noise exposure (which is known to cause damage to the vestibular periphery resulting in postural instability and compromised balance), leading to impaired otolith and semicircular canal function, and thus contributing to imbalance and increased risk of falls. The goal of this supplement is to improve our capacity for otolith function assessment through the purchase of an FDA-approved vestibular evoked myogenic potential (VEMP) measurement device.